A randomized controlled trial of abdominal ultrasound (FAST) in children with blunt torso trauma

PROJECT SUMMARY/ABSTRACT
Hemorrhage from intra-abdominal injuries (IAI) is a leading cause of traumatic deaths in children. Several
consensus panels have placed management of injured children as a high research priority. Many children with
IAIs have subtle symptoms, making the diagnosis difficult, and missed or delayed diagnoses result in
increased morbidity. The combination of limited scientific evidence and concern over missing IAIs has resulted
in excessive use of abdominal computed tomography (CT). CT is highly accurate in diagnosing IAIs, decreases
the level of clinical monitoring required, and is an important factor in determining the need for surgical
treatment. CT scanning also presents risks to children, however, most notably radiation-induced malignancies.
Thus, compelling reasons exist to both aggressively evaluate injured children for IAIs and to limit abdominal CT
evaluation to just those at non-negligible risk. Abdominal ultrasonography can help focus patient evaluation in
just this manner by potentially decreasing abdominal CT use in low risk children. The focused assessment with
sonography for trauma (FAST) examination uses abdominal ultrasonography to detect the presence of
intraperitoneal fluid in injured patients. Use of the FAST examination has primarily evolved in injured adult
patients and two randomized controlled trials (RCT) in injured adults demonstrate that an evaluation strategy
including the FAST improves multiple aspects of patient care including safely decreasing abdominal CT use.
Limited and conflicting data, however, exist in the pediatric population on the utility of the FAST examination. A
large multicenter, observational study suggests FAST safely decreases abdominal CT use in children
considered low risk for IAI. The only RCT in children was a single center study that demonstrated FAST use
significantly decreased clinician suspicion of IAI following a negative FAST. This decrease in clinician
suspicion, however, did not translate to a decrease in CT use. The conflicting results from these studies
strongly suggest the need for a multicenter RCT powered to definitively answer this critical question. The long-
term objective of the research is to determine appropriate evaluation strategies to optimize the care of injured
children, leading to improved quality of care and a reduction in morbidity and mortality. The specific aims of this
proposal are to: 1) perform a RCT of the FAST examination in injured children and compare the frequency of
abdominal CT scanning between children in the FAST and non-FAST arms; 2) identify if an evaluation strategy
including the FAST examination results in similar numbers of missed or delayed diagnosis of IAIs than a
strategy without the FAST examination; and 3) identify patient, physician, and system factors associated with
obtaining abdominal CT scans in patients considered very low risk for IAI by the clinician after a negative FAST
examination. This study will enroll a large sample size (3,180 children) at six diverse sites, and the results will
provide definitive evidence for the role of the FAST examination in children with blunt torso trauma.

Public health relevance
Project Narrative Compelling reasons exist to both aggressively evaluate injured children for intra-abdominal injuries (IAI) and to limit abdominal CT evaluation to solely those at non-negligible risk. The focused assessment sonography for trauma (FAST) examination can help focus patient evaluation in just this manner by potentially decreasing CT use in low risk children, and therefore the overall objectives of this proposal are 1) to determine the efficacy of using the FAST examination during the initial evaluation of children with blunt abdominal trauma, and 2) to identify factors associated with abdominal CT use in children considered very low risk for IAI after a negative FAST examination. The long-term objective of the research is to determine appropriate evaluation strategies to optimize the care of injured children, leading to improved quality of care and a reduction in morbidity and mortality.